Yuva Sath: A peer-led intervention to support substance use treatment and HIV prevention among young people who inject drugs in India

7. PROJECT SUMMARY/ABSTRACT
India’s HIV epidemic is being fueled by an alarming rise in injection of opioids. Young people who inject
drugs (YPWID; 18-29 years of age) are poorly engaged in treatment for opioid use disorder and HIV prevention
services and bear a disproportionate burden of new HIV infections. Increasing engagement in treatment for
opioid use disorder and uptake of HIV prevention services among YPWID is an urgent public health priority.
YRGCARE, an Indian non-governmental organization, has established Integrated Care Centers in 8 cities
to deliver medications for opioid use disorder (MOUD) and other HIV prevention services, including HIV
testing, clean needles, and condoms to people who inject drugs. YPWID initiating MOUD at Integrated Care
Centers engage poorly in treatment due to diverse barriers that also limit uptake of HIV prevention services.
YPWID under-engaged in MOUD have high risk behaviors, low HIV testing, and high HIV seroconversion. Few
interventions exist to support substance use treatment and HIV prevention among Indian YPWID.
Dr. Ganapathi is a pediatric infectious diseases physician who aspires to lead rigorous research to address
this gap. Building upon her HIV research fellowship training and unique clinical background, she will utilize this
Mentored Patient-Oriented Research Career Development (K23) Award to: 1) develop expertise in behavioral
intervention development, 2) gain skills in advanced statistical methods and study design for intervention
research, and 3) develop an understanding of the principles of implementation science.
Dr. Ganapathi will develop and pilot “Yuva Sath”, a brief, peer-led behavioral intervention to support MOUD
engagement and uptake of HIV prevention services among YPWID who have initiated MOUD at Integrated
Care Centers but are under-engaged in treatment. Informed by empirical principles used in successful youth-
tailored interventions, Yuva Sath will be developmentally tailored, leverage peer support, and employ
convenient mobile phone delivery. Development of Yuva Sath will entail adapting “Life-Steps”, an empirically
supported problem-solving intervention originally developed to support antiretroviral therapy adherence.
Intervention development will be informed by: 1) analysis of existing quantitative data collected from a
retrospective cohort of YPWID initiating MOUD across 8 Integrated Care Centers, and 2) collection of
qualitative data to understand YPWID preferences for intervention content and delivery. Dr. Ganapathi will then
conduct a pilot randomized controlled trial of Yuva Sath, compared to usual care, among YPWID at a single
Integrated Care Center in Aizawl city in Northeast India, to inform a future fully powered effectiveness trial.
Leveraging research infrastructure at Harvard Medical School and YRGCARE, Dr. Ganapathi will be
mentored by a multidisciplinary team, with expertise in behavioral medicine, infectious diseases, and addiction
medicine, led by Drs. O’Cleirigh, Solomon, and Mayer. By developing a novel HIV prevention intervention for
YPWID, this work has potential to impact public health while facilitating her transition to independence.

Public health relevance
8. PROJECT NARRATIVE An alarming rise in the injection of opioids is fueling the HIV epidemic in India, with young people who inject drugs (YPWID)—i.e., individuals 18-29 years of age—bearing a disproportionate burden of new HIV infections. We propose to develop Yuva Sath, a novel peer-led behavioral intervention for YPWID—tailored to their unique developmental vulnerabilities—that will support their engagement in substance use treatment and HIV prevention services by addressing the diverse barriers they experience. This research will lead to one of the first youth tailored interventions for HIV prevention among YPWID in India and contribute to urgent efforts to address the high HIV incidence in this vulnerable population.